CARBOXYFULLERENES AS NEUROPROTECTIVE AGENTS

Water soluble derivatives of C60 have been found to act as broadly effective neuroprotective agents in neuronal cell culture models. These compounds also delayed both motor deterioration and death in a transgenic mouse model of amyotrophic lateral sclerosis (ALS). Investigation of these malonic acid C60 derivatives continues. Mass spectrometry provides a means of characterizing these compounds and determining the structure of oxidation products of these derivatives.